A Randomized, Controlled Trial of a Modified Sleep and Circadian Intervention for Veterans with PTSD: Advancing Psychosocial Rehabilitation Through Sleep Health

Sleep disturbance in military veterans with PTSD is a complex condition, typically characterized by insomnia and
nightmares, and frequently accompanied by comorbid obstructive sleep apnea. Each of these problems are
shown to influence the others, contributing to a complex sleep disturbance with profound impacts on daytime
functioning and quality of life. A vicious cycle in which nighttime disturbances impact daytime functioning, and
vice versa, often ensues. Addressing sleep disturbance in veterans with PTSD therefore requires a multipronged
approach that is tailored to each veterans’ constellation of symptoms and each veterans’ goals for sleep health.
The Transdiagnostic sleep and circadian intervention (TranS-C), developed by sleep researchers Allison Harvey,
Ph.D. and Daniel Buysse, M.D., involves a patient-centered, module-based, flexibly structured approach that
tackles numerous sleep disturbances using evidence-based strategies with the overall goal of improving sleep
and improving sleep-related impairments in daytime functioning. It is thus well-suited for tackling sleep
disturbances and the associated impairments in social, occupational and overall functioning in veterans with
PTSD. The proposed study is a randomized, controlled clinical trial examining the effectiveness of a modified
TranS-C intervention for veterans with PTSD. The modified approach, referred to as TranS-C for PTSD (TSC-
PTSD) elevates the importance of nightmare-focused, apnea-focused, and insomnia-focused modules relative
to the standard intervention, incorporates an evidence-based relaxation module, and modifies the nightmare and
apnea modules based on strategies used for veterans in the VA healthcare system. The study will administer
TSC-PTSD remotely to veterans in their homes using a VA-approved video-conferencing platform. The study
will recruit male and female U.S. military veterans aged 18 and above throughout California and compare change
in a comprehensive measure of daytime functioning and change in insomnia, nightmare and overall PTSD
symptoms in participants randomized to the active intervention TSC-PTSD vs. participants randomized to a sleep
psychoeducation control (SPC) intervention. The widely used and validated World Health Organization Disability
Assessment Schedule (WHODAS) will serve as the primary outcome measure. The Insomnia Severity Index
(ISI) and the Clinician-Administered PTSD Scale (CAPS) will be used to measure secondary outcomes. Eligible
participants will have an insomnia diagnosis, a PTSD diagnosis (or moderate symptoms of PTSD in the absence
of a full diagnosis), and clinically significant nightmares based on gold-standard clinician-administered interviews.
All participants will complete baseline surveys related to daytime functioning and sleep-related symptoms prior
to treatment initiation, and will complete these surveys again in week 5, and at the end of treatment. For additional
high-resolution data on sleep patterns, all participants will record sleep-related information, including nightmare
occurrence and severity, in the morning and at bedtime using a veteran-tested and user-friendly sleep diary
mobile app. Participants will also complete the clinical interview and self-report surveys at 3-month and 6-month
follow-up, to assess the durability of treatment effects. The duration of TSC-PTSD may vary between a minimum
of 8 and a maximum of 12 sessions and the psychoeducation control protocol will involve 10 sessions. Our
hypotheses are: 1) subjects randomized to TSC-PTSD will demonstrate greater improvement in WHODAS score
relative to SPC from baseline to post-treatment; 2) subjects randomized to TSC-PTSD will demonstrate greater
improvements in insomnia, nightmares and PTSD symptoms as demonstrated by improvements in the ISI, CAPS
distressing dreams score, and CAPS total score relative to SPC from baseline to post-treatment; and 3) subjects
randomized to TSC-PTSD will demonstrate greater sustained improvement in functional and clinical outcomes
at 3-month and 6-month follow-up relative to SPC, and improvements in WHODAS score will be mediated by
improvements in ISI, nightmares and TranS-C indicators of sleep health in both study groups. Findings in support
of our hypotheses will provide a vital new tool for advancing rehabilitation in U.S. military veterans with PTSD.

Public health relevance
Sleep disturbances, including insomnia and nightmares, are core and disabling features of PTSD in U.S. military veterans. Several sleep disorders, especially obstructive sleep apnea, also co-occur frequently with classic PTSD sleep disturbances. These all lead to problems in daytime occupational, social and relationship functioning, and research indicates that they contribute to numerous negative health outcomes, including suicide. Finding effective solutions for the complex sleep disturbances that veterans with PTSD experience is therefore critical. TranS-C is a comprehensive, module-based psychotherapy strategy aimed at improving sleep and sleep-related functional impairments. It has been tested and shown to be effective in non-veteran studies. It is flexible and patient-centered, focused on actively engaging clients in the treatment planning and targeting each client’s unique sleep issues and treatment goals. This study will test TranS-C in veterans with PTSD, with modifications aimed at enhancing its effectiveness for veterans with PTSD specifically.